Core A: Administrative

The specific aim of Core A is to provide administrative support for the Program Project entitled Making Sense of Voltage Sensors. The Program consists of three Research Projects and three Core Projects (including Core A). Total Program staffing includes four principal investigators, a senior investigator, and eight postdoctoral scholars located variously at UC Irvine (2 departments), the University of Pennsylvania, and the NIST Center for Neutron Research. Core A provides the administrative resources necessary for creating a coordination and support center for the entire Program. It will support 5% of the effort for the Program Director and a full-time administrative assistant (AA), who will assist the Director in the overall mangement of the Program. The AA will in addition provide general adminstrative support to the Project Pis for travel related to Program management and for the preparation and submission of reports, budgets, and publications. Core A provides resources for Project Pis to attend three PI conferences each year, which will rotate between the three performance sites. Resources are also requested for travel for Program Director to make regular oversight visits to the NIST Center for Neutron Research and the University of Pennsylvania.

Public health relevance
Core A is the administrative core for a Program Project that investigates how ion channels gate the flow of ions across nerve, muscle, and cardiac cells in response to changes in voltage across their cell membranes. These voltage changes, called action potentials, are the means by which nerve, muscle, and cardiac cells communicate with each other. Many neuromuscular and cardiac diseases arise from defects in the way action potentials are produced. Results from this Program will help us understand the origin of such diseases.